MIDWEST PROGENITOR CELL CONSORTIUM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Objective: To convert human pluripotent stem and somatic cells into hematopoietic stem cells (HSCs) and self renewing cardiac progenitor cells. The Midwest Progenitor Cell Consortium is a collaboration between the UW-Madison and the University of Minnesota, which will serve as a research hub within the NHLBI's Progenitor Cell Biology Consortium. The goal is to develop new strategies to convert human pluripotent stem and somatic cells into hematopoietic stem cells (HSCs) and self renewing cardiac progenitor cells through identification of genetic program leading to formation of pre-HSCs and cardiac progenitors and activation of self-renewal program in lineage restricted cells. Dr. Slukvin's involvement in the consortium relies on WNPRC Stem Cell Resources.